Development and pilot testing of a novel text messaging intervention to improve emergency department care transitions among care partners of persons living with cognitive impairment

PROJECT SUMMARY/ABSTRACT
The majority of persons living with cognitive impairment (PLWCI) are discharged after seeking care in the
emergency department (ED), with informal care partners (e.g. family members, friends) subsequently providing
a significant amount of hands-on care and navigation of health-related and social needs within this vulnerable
time period. There exists a critical need to develop pragmatic ED care transition interventions to support care
partners given the growing population of PLWCI seeking emergency care, the adverse outcomes that PLWCI
experience after ED discharge, the outcome interconnectedness between PLWCI and care partners, and the
limited generalizability and effectiveness of interventions to date. The candidate, Dr. Gettel, is an emergency
physician at the Yale School of Medicine with a track record of early success and preliminary findings through
an NIA GEMSSTAR Award identifying that care partners of PLWCI experienced poor, if any, communication
during ED discharge. Digital health interventions (e.g. text messaging) have previously shown promise as a
pragmatic tool for communication in various ED populations, yet no evaluations have assessed these
approaches in the population of care partners of PLWCI despite their acceptance of digital health and the
capability of digital health tools to disseminate information beyond the physical confines of the ED encounter.
The objective of this proposal is to develop and pilot test the CAre Partner Text message intervention to
improve futURE outcomes (CAPTURE), an ED care transition intervention delivered via automated tailored text
messaging that will provide information, core medical reminders and behavioral strategies, and practical
support to care partners of PLWCI. Sequential exploratory mixed-methods approach will be used to achieve
the three aims: 1) Elucidate facilitators and barriers to the use of an ED-based text message care transition
intervention among care partners of PLWCI; 2) Develop and iteratively refine the CAPTURE using user-
centered design methods for care partners of PLWCI quantitatively measuring usability, feasibility, and
acceptability; and 3) Determine the feasibility and preliminary efficacy of the CAPTURE implementation after
an ED visit in care partners of PLWCI compared to a care partner population receiving usual care.
Responsive to the “National Institute on Aging: Strategic Directions for Research, 2020-2025”, findings of
this proposal will expand supports and address the special needs of care partners of PLWCI. During the award
period, Dr. Gettel will pursue career development training activities leveraging the team’s mentorship expertise
in the domains of: geriatric emergency medicine; text message interventions; ADRD and care partners; patient-
and caregiver-reported outcome (PCRO) measurement; embedded pragmatic clinical trial (PCT) design; and
implementation science. Findings will inform an NIA R01 proposal to assess the real-world efficacy and
effectiveness of the CAPTURE implementation and its impact on PCROs as part of a multisite embedded PCT.

Public health relevance
PROJECT NARRATIVE Care partners of persons living with cognitive impairment (PLWCI) provide a significant amount of hands- on care and navigation of health-related and social needs after emergency department (ED) visits, with little evidence to date of pragmatic and effective care transition interventions. This proposal seeks to design, implement, and test the feasibility of the CAre Partner Text message intervention to improve futURE outcomes (CAPTURE), an ED care transition intervention delivered via automated tailored text messaging that will provide information, core medical reminders and behavioral strategies, and practical support to care partners of PLWCI. This work has the potential to inform and improve ED discharge care transitions that substantially influence subsequent trajectories of PLWCI and their care partners.